Glucagon Pump Therapy for Post-Bariatric Hypoglycemia: Merging Physiology and Engineering

Project Summary/Abstract
Bariatric surgery is a potent treatment for obesity-related metabolic disease and markedly improves glucose
control in T2D. However, along with this metabolic success comes an increased risk of severe hypoglycemia
(termed post-bariatric hypoglycemia, or PBH), with estimated prevalence of up to 30% of patients after both
gastric bypass and sleeve gastrectomy. Current therapies for PBH are limited and incompletely effective, and
individuals with severe hypoglycemia and unawareness lack sufficient warning to treat before rapid onset of
neuroglycopenia and impaired safety.
Previous studies of PBH by our group and others have demonstrated potential drivers of hypoglycemia in this
condition: (1) increased insulin secretion, linked to postprandial incretin secretion (including GLP1), (2) increased
insulin-independent glucose uptake, (3) reduced secretion of glucagon and other counterregulatory hormones,
and (4) altered intestinal metabolism. One promising approach to prevent and treat severe hypoglycemia in PBH
is closed-loop glucagon therapy. In prior studies, we collaborated with engineering colleagues to develop and
test a closed-loop system which utilized CGM in combination with a novel closed-loop algorithm to detect
incipient meal-related hypoglycemia and deliver boluses of glucagon via a patch pump. Using a double-blind,
placebo-controlled crossover pilot study in the clinical research unit, we demonstrated efficacy and safety of this
closed-loop glucagon pump system, with increased nadir glucose after mixed meal and reduced need for rescue
glucose. Buoyed by the success of these meal-focused studies, we now propose to further define glucagon
sensitivity, secretion, and turnover and glycogen metabolism in PBH, in order to develop an enhanced, more
effective, closed-loop glucagon algorithm and clinical therapeutic system responsive to glycemic excursions
which occur not only during the postprandial period, but also during overnight hours and during/after activity.
To achieve this goal, we have assembled a multidisciplinary team including clinical investigators with expertise
in PBH and glucagon and glucose metabolism, and biomedical engineers with expertise and an established track
record in closed-loop pump system development and clinical testing and implementation. Thus, the proposed
studies will address an important knowledge and therapeutic gap in PBH, and provide four innovative
deliverables to advance our understanding of and the clinical care of this challenging patient population: (1) key
quantitative data for glucagon sensitivity, secretion and turnover and glycogen metabolism as contributors to
hypoglycemia during postprandial, postabsorptive, and post-activity states in PBH, (2) development of an in silico
model of the PBH patient, allowing implementation and testing of a novel CLG algorithm, (3) implementation of
the CLG algorithm in a system driving on-body pump delivery of microdoses of glucagon guided by CGM data,
and (4) after regulatory approval, completion of a pilot randomized outpatient, hotel-based clinical trial of the
CLG system in patients with PBH.

Public health relevance
Project Narrative Bariatric surgery is a potent treatment for obesity-related metabolic disease and improves glucose control in T2D, but some individuals develop severe hypoglycemia (post-bariatric hypoglycemia, PBH), threatening safety. PBH is linked to increased insulin and incretin secretion, reduced secretion of glucagon and other counterregulatory hormones, and altered intestinal and whole-body metabolism, but current therapies remain incompletely effective. In this study, we will (a) analyze glucose and glucagon metabolism/sensitivity in the fasting, post-meal, and post-exercise states in patients with PBH, (b) use this information to develop a new closed-loop glucagon pump system responsive to the unique pathophysiology of PBH, and (c) test the system in a pilot randomized outpatient clinical trial.